Uncovering the Neural Mechanisms that Flexibly Link Sensory Processing to Behavior

PROJECT SUMMARY
Over the past eight years, my lab has pioneered studies of the acoustic communication system of Drosophila,
to address fundamental questions related to the neural mechanisms underlying sensory perception and the
generation of behaviors. Similar to other animals, flies produce and process patterned sounds during their
mating ritual. Using a combination of novel behavioral assays, neural circuit perturbations, neural recordings,
and computational modeling, we discovered that male song structure and intensity are continually sculpted by
interactions with the female, over timescales ranging from tens of milliseconds to minutes. Building on this
finding, we have gone on to dissect the neural mechanisms underlying the visual modulation of song patterning
in males. Using a similar set of tools, we have also interrogated the female side of acoustic communication,
and have successfully related song representations along the auditory pathway to changes in locomotor
behavior, again across multiple timescales. My lab has developed several new methods to facilitate these
studies, including methods for tracking and segmenting animal behavior, for population neural imaging, and for
single-cell transcriptomics in the Drosophila brain. Our system and discoveries lay the essential foundation for
now solving the bigger challenge of how an animal’s internal state and experiences contribute to shaping these
neural mechanisms. To do so, we will employ new computational models to identify the neural correlates of
internal state. We will also use a new paradigm to induce learning during acoustic communication, and will
characterize how learning shapes sensorimotor integration in this system. Finally, we will manipulate the
hunger or arousal status of flies to determine, again at the cellular level, how long timescale modulation of
neural activity shapes fast timescale sensorimotor processes. These new research directions will leverage the
methods we have optimized for the recording and analysis of neural and behavioral data, in addition to
incorporating new methods for recording activity in behaving flies that experience naturalistic, multimodal
courtship stimuli timed to their movements on a spherical treadmill. What we discover in this system will reveal
fundamental principles regarding how brains mediate perceptions, thoughts, actions, and ultimately the ability
to communicate with another individual.

Public health relevance
PROJECT NARRATIVE This proposal leverages the Drosophila model system to address the neural mechanisms underlying social interactions, from processing of cues emitted by a communication partner to generating complex behaviors in response to those cues. Impairments in processing sensory information or generating motor behaviors, particularly in the context of social interactions, underlie several human disorders including Parkinson’s disease and Autism spectrum disorder. This proposal will uncover general principles of neural circuit function that will inform studies of sensorimotor integration in more complex systems.